In vivo testing of structure-based vaccine candidates targeting Alzheimer’s disease

Protein misfolding is a significant contributor of neurodegenerative diseases, leading to
pathological aggregation and potential gain of toxic function. Thus, strategies targeting the
clearance of misfolded proteins such as A-beta and tau have shown promise in reducing or
slowing of the amyloid deposition including immunotherapies. Passive immunization with
antibodies against aggregated A-beta are not only costly but also with limited efficacy in
maintaining cognitive function and fit for only a small pool of eligible patients. Active
immunization with engineered constructs using HET-s as a scaffold while carrying key
conformational epitopes present on the surface of alpha-synuclein fibrils has significantly
prolonged the survival of mice with Parkinson's disease. Anti-sera from mice immunized with
constructs made of HET-s and key structural residues from paired-helical filaments (tau) and Aβ
fibrils are immunoreactive to brain homogenates from both sporadic and familial forms of human
Alzheimer’s disease patients. The goal of this study is to determine the efficacy of our active
immunization strategy in prophylactically preserving cognitive and neural function by slowing the
formation of A-beta amyloid or paired-helical filaments in the brain. To that end, 5xFAD mice will
be immunized with a quadrivalent vaccine composed of 4 top performed constructs targeting Aβ
during adolescence, and tested for memory function by Y-maze, novel object recognition and
Barnes maze tests at nine months of age, followed by in vivo extracellular recording using
multichannel electrodes spanning the cortex and the hippocampus. Similarly, hTau mice will be
immunized with our top vaccine construct targeting tau and subjected to the same battery of
behavioral tests and electrophysiological recording. Brains will be examined for the amount of
amyloid deposits and hyperphosphorylated tau, respectively. Perl’s stain will be used to detect
potential side effect of microhemorrhage known to human AD patients receiving
immunotherapy. Using in vitro and in vivo assays we will also determine whether the designed
vaccine constructs activate the complement system, as this information can be used for further
refinement of the vaccines to enhance the efficacy of the immune response for robust clearing
of misfolded proteins and preventing cognitive decline.

Public health relevance
Neurodegenerative diseases have devastating consequences to family, caregiver and society beyond personal suffering, yet up to this date there are limited treatment options to retain cognitive function of patients with Alzheimer’s disease or dementia. We propose to test the efficacy of engineered vaccines to reduce Alzheimer’s disease proteins and preserve cognitive function in mice models of Alzheimer’s disease.